Real-Time eXperiment Interface - Enabling closed-loop biological experiment control

Project Summary/Abstract
The ability of experimentalists to investigate biological systems has often been limited to pre-programmed
open-loop protocols whereby systems are probed based on assumptions and predetermined models. In
contrast, real-time feedback control allows systems to be dynamically probed with parameter perturbations
calculated as functions of instantaneous closed-loop system measurements, enabling researchers to
address questions not amenable to open-loop approaches. While there are many biological problems that
can be made more tractable by such feedback control – such as dynamic probing of ion-channel function in
neurons or manipulation of sleep network dynamics using auditory and electrical stimuli governed by real-
time EEG feedback – technical complexities often hinder its adoption.
Because there has been a many-decades advance in computing technologies, it is counter-intuitive that
real-time experiment control is not possible with standard computer operating systems (without expensive
add-on components). They are simply not designed for such strictly timed tasks. Furthermore, commercial
real-time systems are costly and require end-user customization for the lab, such that they are typically not
portable to the broader scientific community. To circumvent these limitations, we developed a fast and
highly versatile real-time biological experimentation system – the Real-Time eXperiment Interface (RTXI).
RTXI is free and open source, compatible with an extensive range of experimentation hardware, and
delivers reproducible, hard real-time performance via a user-tailorable interface on standard laboratory
computers. Importantly, RTXI offers extensive versatility and high-performance to “power users,” while
simultaneously providing a rich – and ever growing – library of experiment-control modules that require little
effort for those who are not computationally savvy.
RTXI has grown to the point where it is now an invaluable part of the scientific programs of many leading
research groups. In addition to updating and maintaining RTXI for those, and future, users, there remain
important avenues for development that would substantially expand RTXI’s functionality, reproducibility
enhancement, and utility for an even broader group of biological researchers. Thus, we propose:
1. To keep RTXI pushing scientific innovation by overhauling its base code and core modules.
2. To enable several new real-time experiment paradigms.
3. To ease and enrich experimentalists’ user experience and reproducibility.
Critically, the work proposed here will ensure that RTXI remains a valuable research tool for its varied
group of outstanding biological scientist end users. Furthermore, we will expand RTXI’s utility significantly
by building and supporting additional classes of experiments and the groundbreaking science they will
enable.

Public health relevance
Project Narrative Experimentation protocols are not always capable of deeply probing the mechanisms of complex biological systems. We have developed a free, customizable, open-source software system, known as Real-Time eXperiment Interface (RTXI), that enables experimentalists to perform reproducible innovative protocols that are adapted on-the-fly to optimize information acquisition and experiment control during the course of an experiment. This project, which aims to expand the functionality of RTXI in multiple critical ways, will further the abilities of biological scientists to use such protocols to investigate important questions for biological systems ranging from the heart to the brain.